Targeting the vasculature to enhance anti-tumor immunity

SUMMARY
Tumor blood vessels allow anti-tumor immune cells to enter the tumor microenvironment, but abnormalities in
the tumor endothelium can impair immune cell entry, resulting in poor responses to immune checkpoint
blockade (ICB). We recently found that genetic deletion of the epigenetic gene silencer DNA methyltransferase
1 (Dnmt1) in blood vessels primes the endothelium for cytokine stimulation, resulting in improved responses to
ICB. This suggests that epigenetic reprogramming of the tumor vasculature could improve the efficacy of ICB
and augment immune surveillance. We have now used melanoma cells with differing tumor mutation burden
(TMB) and found that targeting Dnmt1 in the endothelium results in notable regression of TMBhi melanoma,
increased CD4/CD8 memory T-cells and granzyme B+ effectors, increased dendritic cells and lymphatic
vessels in tumor-draining lymph nodes, and a profound reduction in lung-metastatic burden following
combinations of ICB. In this proposal, we aim to test three hypotheses: first, that genetic disruption of Dnmt1
in endothelial cells promotes long-term tumor control via dendritic cell trafficking to draining lymph nodes and
recruitment of CD4+ T-cells; second, that targeting Dnmt1 in the vasculature of melanoma lung metastasis will
reduce tumor burden and improve the efficacy of ICB; and third, that switching off endothelial Dnmt1 will
promote the neogenesis of immune-permissive post-capillary venules and high endothelial venules in
melanoma. This renewal proposal is led by Dr. Andrew Dudley, a Professor of Microbiology, Immunology, and
Cancer Biology at UVA. Dr. Dudley is the MPI on the T32 Cancer Biology Training Grant at UVA, a member of
the UVA Comprehensive Cancer Center, and he runs a research lab focused on tumor angiogenesis/tumor
microenvironment. The proposal also includes Dr. Hong Zhu, a biostatistician and director of the Biostatistics
Share Resource Center in the Department of Public Health Sciences, who will guide data analysis and
statistics. Additionally, Dr. Melanie Rutkowski, an expert in using FACS to profile immune cells in tumors, and
Dr. Craig Slingluff, a surgical oncologist with over 30 years of experience in cancer immunology and
immunotherapy at UVA, are included on the proposal. Dr. Slingluff's research includes laboratory studies and
clinical trials focused primarily on developing melanoma vaccines and combination immunotherapy. Taken
together, a successful proposal will inform the development of vascular-directed therapies that can increase
ICB efficacy against metastatic disease, identify creative approaches to lower the effective dose of ICB
required for a favorable and sustained response, and further our understanding of how tumor vascular
heterogeneity dictates anti-tumor immunity.

Public health relevance
NARRATIVE Immune checkpoint blockade (ICB) is a promising anti-cancer strategy, but advanced metastatic cancers are still challenging to treat effectively. This proposal aims to enhance the efficacy of ICB in treating metastatic and primary melanoma by targeting tumor blood vessels, making them more permissive for the entry of anti-tumor immune cells into the tumor microenvironment. The ultimate goal is to develop vascular-directed therapies that can improve ICB efficacy against metastatic disease and reduce the effective dose of ICB required for a positive and long-lasting response.